Targeting Metabolic Reprogramming in ER+ Breast Cancer

Project Summary: Adjuvant endocrine therapies are effective in treating estrogen receptor-positive (ER+)
breast cancer, but drug-tolerant persister cancer cells (DTPs) contribute to cancer recurrence in approximately
1/3 of patients. Thus, targeting DTPs is an attractive therapeutic approach, but it has been hampered by a lack
of understanding of DTP biology. Our long-term goal is to discover vulnerabilities of DTPs that can be thera-
peutically targeted. The overall objective of this project is to determine the consequences of, and vulnerabilities
created by, metabolic reprogramming in ER+ breast cancer cells that enable tolerance of estrogen deprivation.
Our central hypothesis is that estrogen deprivation induces reprogramming of energy metabolism that creates
therapeutic vulnerabilities in ER+ breast cancer DTPs. The rationale for this project is that identification of the
vulnerabilities of DTPs in ER+ breast cancer will enable the rational development of therapeutic strategies to
target DTPs and prevent cancer recurrence. The central hypothesis will be tested by pursing two specific aims:
1) Determine the effects of estrogen deprivation on energy metabolism in ER+ breast cancer; and 2) Deter-
mine the metabolic vulnerabilities conferred by ER+ breast cancer cell persistence during estrogen deprivation.
The first aim will utilize ER+ breast cancer cells to measure the effects of estrogen deprivation on bioenerget-
ics and underlying mechanisms. In the second aim, we will measure the effects of inhibition of mitochondrial
oxidative phosphorylation on the source and amount of ATP production, and on cell fate in endocrine-sensitive
and endocrine-persistent ER+ breast cancer cell lines and tumors. Results from these studies will provide a
fundamental understanding of how metabolic reprogramming creates vulnerabilities in bioenergetic depend-
ence, and provide data to guide clinical testing of metabolic disruptors to induce energetic catastrophe in ER+
breast cancer. The acquisition of such knowledge is essential to the development of improved therapeutic
strategies to target endocrine-persistent breast cancer cells. The proposed research is innovative because it
will test the therapeutic potential of suppressing OXPHOS to elicit energetic catastrophe as well as elucidate
the mechanism underlying bioenergetic shifts in breast cancer cells that survive endocrine therapy. The pro-
posed research is significant because it will implicate OXPHOS reliance as a therapeutic vulnerability in DTPs
and provide justification for clinical testing of metabolic disruptors. The environment at Dartmouth College and
Dartmouth Cancer Center is ideal for the proposed translational research with a long-standing history of clini-
cian-scientist collaborations and cancer research support. The cadre of assembled Sponsoring Team mem-
bers will provide support in both research and clinical mentorship with expertise, materials, and dedicated pre-
ceptorship time. Together with the outlined training plan, the proposed work will support the Applicant’s career
plan to become an independent, highly productive physician-scientist focused on oncology.

Public health relevance
Project Narrative: The proposed research is relevant to public health because it focuses on the development of therapies for people with ER+ breast cancer. Once strategies to target drug-tolerant cancer cells have been developed, there is potential for significant improvement in the prevention of cancer recurrence and progression. Thus, the proposed research is relevant to the mission of the NCI to improve cancer survivorship by reducing breast cancer morbidity and mortality.